COMPARING TWO METHODS OF OBTAINING BLOOD CULTURE SAMPLES FROM NEONATES

Two methods of obtaining blood cultures from neonates have been documented. Traditionally, the sample has been obtained by peripheral venipuncture which is often a difficult procedure. An alternative is to obtain the blood sample from the umbilical vein. A comparison will be made between both methods to determine the efficacy of each.